Cortical Plasticity Across Phase of Illness in Schizophrenia

PROJECT SUMMARY
Individuals with schizophrenia suffer from marked cognitive impairment, which is highly predictive of social,
occupational, and community functioning. As a result, cognitive impairment is a prime target for intervention.
Abnormalities in cortical plasticity are hypothesized to underlie cognitive impairment. However, because it was
not possible to evaluate human cortical plasticity in vivo until very recently, the extent to which cortical plasticity
is impacted in schizophrenia is unclear. Furthermore, it is unknown whether cortical plasticity changes over
phase of illness. Animal studies indicate that cortical plasticity declines with age. It is possible that in
schizophrenia, normative maturational declines in cortical plasticity interact synergistically with disease
pathophysiology over the developmental course of the illness. Thus, cortical plasticity may be less
compromised in the early phase of illness. Finally, little is known about the real-world consequences of
abnormal cortical plasticity for individuals with schizophrenia. This K23 project is consistent with strategies
outlined in the NIMH Strategic Plan, particularly Strategy 1.1., to describe the neural circuits associated with
complex behaviors, Strategy 2.1, to characterize the developmental trajectories of brain maturation and
dimensions of behavior to understand the roots of mental illnesses across diverse populations, and
Strategy2.2, to identify clinically useful biomarkers that predict change across the trajectory of illness.
Specifically, the proposal involves a plan for the applicant to work closely with a diverse team of distinguished
researchers with expertise in neuroscience, clinical and developmental psychology, and biostatistics to
investigate biomarkers of cortical plasticity in schizophrenia within a neurodevelopmental framework. Using
newly-developed EEG paradigms that permit non-invasive assessment of plasticity in the human sensory
cortex, we will study individuals with recent-onset schizophrenia, chronic schizophrenia, and matched non-
psychiatric comparison participants to investigate:1) whether cortical plasticity is abnormal in schizophrenia,
2)whether cortical plasticity changes over phase of illness, and 3)potential correlates of cortical plasticity in
schizophrenia, including performance-based tasks of perceptual processing and higher-order cognition, and
daily functioning. The findings will inform the field about the developmental course of the neural underpinnings
of impaired cognition in schizophrenia, and will inform plasticity-based interventions to improve cognition in this
population. Mentored training in advanced EEG analytic methods and developmental psychopathology will
permit the applicant to develop an independent, interdisciplinary program of clinical research that combines
electrophysiology and behavioral methods to investigate cognition and functioning in severe psychopathology
across the lifespan.

Public health relevance
PROJECT NARRATIVE Beyond the obvious personal costs, the cost of schizophrenia to society is tremendous; the economic burden of schizophrenia exceeds $62 billion in the US, and approximately 50% of the total can be attributed to costs associated with impaired functioning. Using advanced EEG methods within a neurodevelopmental framework, this project will investigate the neural underpinnings of impaired cognition, a major predictor functional disability in schizophrenia, to determine whether neural processes become increasingly abnormal over the course of illness, and to identify external correlates of the neural processes. This research is expected to inform developmental and treatment research regarding the trajectory of impaired cognition over phase of illness in schizophrenia, and indicate optimal timing for cognitive training interventions